Investigating the role of human-specific 3D genome conformation in the context of brain development and disease

PROJECT SUMMARY
The human brain has undergone many specializations (e.g., increased synapse density) resulting in
unmatched cognitive complexity, as well as increased vulnerability to neurodevelopmental disorders, such as
autism. Differences in gene expression are responsible for most human-specific brain specializations, and
comparative (epi)genomics strategies are remarkably powerful in identifying the mechanisms underlying these
differences. Spatial genome conformation, particularly organization of topologically associated domains
(TADs), is a very promising candidate mechanism for driving human-specific gene expression patterns in the
brain but remains understudied in this context. In our preliminary comparative investigation, we found that
human-specific TAD organization in lymphoblastoid cells are associated with neurodevelopmental genes, and
are recurrently disrupted in patients with developmental delay. However, genome conformation differs
drastically across tissues, thus accurate identification of human-specific TAD organization and understanding
its contributions to neuronal development and pathology can only be achieved by investigating genome
conformation in brain cells. To this end, here we will analyze well-validated cortical neuroprogenitor cells
(NPCs) and glutamatergic neurons in human and other primates to identify human-specific TAD boundaries,
predict their functionality through in silico mutagenesis, and validate their contribution human
neurodevelopmental specialization and disease by using targeted genome editing. In Aim 1, we will obtain Hi-
C data from cortical NPCs and mature neurons derived from induced pluripotent stem cells (iPSC) of human,
chimpanzee, orangutan, and rhesus macaque using well-validated differentiation protocols. Human-specific
TAD boundaries identified in these cells will also be compared against primary NPC and neuron data to
validate findings in-vivo. We will complement our findings with epigenetic and transcriptomics data from the
same cells and species, to identify differential gene expression and genomic and epigenetic signatures
associated with human-specific TAD organization. In Aim 2, we will use novel computation tools to predict
effects of disrupting each human-specific boundary and prioritize 15 candidates whose disruption is most likely
to cause neuropathogenicity. We will use CRISPR-Cas9 to delete these candidates in human iPSC-derived
NPCs and neurons. The molecular consequences of each deletion on chromatin interactions/structure and
gene expression will be assessed, along with
electrophysiology (for neurons) or
proliferation assays (for NPCs)
to study the physiological consequences. We will then select a subset of 5 most effective candidates and
knock them into chimpanzee iPSC, followed by differentiation to NPC and neurons. “Humanized” chimpanzee
cells will be characterized at the molecular and physiological level like the human knockout lines, to further
shed light on the function of human-specific TAD boundaries to human neurodevelopment. Overall, this study
will provide new insights into mechanisms underlying human-specific brain development and disease.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it investigates how the spatial organization of the human genome might be related to the evolution of brain development and how its disruption might lead to neurodevelopmental disorders. The proposed research is relevant to the NIH’s mission of increasing knowledge in order to reduce disease.